Stem-like T cells as bioindicators and orchestrators of the disease process in MS and animal models

There is an urgent need for a better understanding of the propagation of encephalitogenic autoimmune
responses and the identification of relevant immune cells and their specific characteristics, which could serve as
biomarkers and therapeutical targets. CD4+ T cells show critical pathogenic roles in multiple sclerosis (MS) in
preclinical models and human disease. Within the central nervous system (CNS), the encephalitogenic
autoimmune CD4+ T cells infiltrate the MS brain lesions, and these T cells recirculate to the peripheral immune
system, where they can be maintained and activated. The mechanisms that support long-term maintenance of
the pro-encephalitogenic autoimmune CD4+ T cells remain a mystery. The long-lived stem-like CD4+ T cells
(CD4+ TSTEMS) with enhanced capacities for effector differentiation were proposed to contribute to the onset and
exacerbation of MS disease in humans and in the corresponding animal models. Unlike the well-characterized
CD8+ TSTEMS involved in anti-tumor and anti-viral immune responses, these MS-related autoimmune CD4+ TSTEMS
are still understudied. Moreover, the current markers of CD4+ TSTEMS are contextual, e.g., T cell factor 1 (Tcf1,
encoded by Tcf7) is expressed in non-stem cells, including naive T cells. A lack of precision analytical tools and
clearly defined markers hinders further progress in understanding the stem-like paradigm. Our published results
uncovered that pro-encephalitogenic CD4+ pre-effectors de novo induced from naive T cells become
programmed for diverse autoimmune TEFFS differentiation in an MS model, lending support to the stem-like
paradigm. We developed a strategy to overcome the lack of biomarkers issue by identifying a consensus
signature from the transcriptomes of various bona fide stem cells. We used this consensus signature and
identified a conserved stemness transcriptomic profile specifically in mouse pre-effectors and human T cells from
the peripheral blood of MS patients but not in MS-free controls. Furthermore, we have developed a new single-
cell sequencing analytical approach enabled by an advanced scoring method, which retrieves biologically
relevant information based on the cumulative expression of multiple genes involved in specific biological
processes. We extend these exciting research endeavors in this proposal and dedicate Aims 1 and 2 to rigorously
test the hypothesis that a continuing stemness and encephalitogenic TEFFS differentiation results in a functional
and transcriptomic diversification of CD4+ TSTEM lineages under evolving autoimmune conditions. Furthermore,
we have also found increased expression of the homeodomain-only protein (Hopx), in pro-encephalitogenic pre-
effectors. Mouse Hopx and human HOPX are well-established orchestrators of stemness in progenitor
populations. Intriguingly, we found that Hopx also critically enhanced the survival of Foxp3+ TREGS, suppressing
disease in MS models. Therefore, in Aim 3, we will test the hypothesis that Hopx orchestrates independent
mechanisms in pro-encephalitogenic TSTEMS and anti-encephalitogenic TREGS, resulting in functionally opposing
outcomes impacting the autoimmune response.

Public health relevance
Stem-like T cells are proposed to orchestrate autoimmune responses, but little is known about the role of CD4+ encephalitogenic stem-like T cells. We have designed new ways to identify and characterize these cells using state-of-the-art transcriptomic signatures based on multiple genes rather than relying on the conventional single-gene approach. These new analytical tools will help develop these stem-like CD4+ T cells as novel bioindicators of MS, and the outcome of these studies will have both scientific and translational impact.